EVOLV-Rx VA: Evaluating Opportunities to Decrease Low-Value Prescribing in Community Living Centers

Background: More than half of Veterans aged 65 years who reside in Community Living Centers (CLCs) are
subject to low-value prescribing, placing them at increased risk of adverse drug events, hospitalization, and
death. CLCs represent an ideal setting to safely reduce low-value prescribing; however, no intervention to
broadly reduce low-value prescribing has been successfully integrated into routine care or implemented at scale
across CLCs. In response, we developed EVOLV-Rx (Evaluating Opportunities to Decrease Low-Value Prescrib-
ing), a novel clinical support tool to detect 18 evidence-based and clinically useful low-value prescribing practices
in older adults per an expert Delphi panel and further informed by patient, caregiver, and clinician input.
Significance: Our objective is to conduct a hybrid study to assess the effectiveness and implementation of an
EVOLV-Rx-based intervention to reduce LVP among older Veterans who reside in CLCs in VISN 4. This study
will support VA's evolution as a learning healthcare system and is aligned with VA's key strategic healthcare
priority of becoming the most age-friendly healthcare system in the United States. It also aligns with two VA HSR
topic areas of interest, including improving healthcare quality and value and long-term care and aging.
Innovation & Impact: EVOLV-Rx is a novel tool to detect low-value prescribing. Its unique characteristics and
automated application will enable pharmacists to provide detailed recommendations to clinicians to prioritize
medications for deprescribing with high clinical impact and that may be acceptably deprescribed from the per-
spective of patients and caregivers. EVOLV-Rx represents a substantial departure from the status quo, and its
use will enhance deprescribing in CLCs and overcome several previously described implementation barriers.
Specific Aims: 1) To finalize the adaptable elements of, and implementation playbook for, the EVOLV-Rx inter-
vention to reduce low-value prescribing for older Veterans residing in CLCs, 2) To assess the effectiveness of
the EVOLV-Rx intervention to reduce low-value prescribing, 3) To evaluate and iteratively improve the implemen-
tation of the EVOLV-Rx intervention.
Methodology: Using the Theradoc clinical support platform, our intervention is an electronic EVOLV-Rx dash-
board used by pharmacists to provide deprescribing recommendations to clinicians to reduce LVP as part of
each Veteran's required medication review. Our intervention will be translated into clinical practice in VISN 4
CLCs using a playbook of core implementation strategies previously employed in VA and additional strategies
determined by key shareholders to address specific implementation barriers identified as part of the study. In
Aim 1, we will conduct focus groups of VISN 4 CLC leaders, clinicians, Veterans, and family caregivers, where
we will characterize the patient, clinician, and CLC-level barriers to and facilitators of implementation; and identify
and tailor strategies to optimize the intervention's adoption and implementation. In Aim 2, we will conduct a hybrid
type 2 effectiveness implementation trial to compare the intervention to usual care, using a stepped wedge de-
sign in five VISN 4 CLCs. Our primary effectiveness outcome is the count of low-value prescribing practices per
100 Veterans. In Aim 3, we will conduct an embedded process evaluation to study implementation processes,
their impact on outcomes, and iteratively improve the implementation of the intervention. We will also conduct
semi-structured interviews of clinicians, Veterans, and family caregivers to characterize the appropriateness,
feasibility, acceptability, and perceived effectiveness of the intervention and implementation strategies employed.
Next Steps/Implementation: Leveraging VA infrastructure, the commitment of our operational partners, and the
deep expertise of our research team, this proposal will result in a scalable intervention and accompanying im-
plementation playbook to reduce low-value prescribing among Veterans receiving care in CLCs. It will also inform
its deployment as a national multi-site trial to further evaluate and optimize its implementation throughout VA.

Public health relevance
The long-term goal of this research is to improve the quality and value of older Veteran's care by reducing low- value prescribing. This study will advance VA's understanding of whether a novel automated tool may be used by pharmacists, physicians, and advanced practice providers to effectively reduce low-value prescribing among older Veterans who reside in Community Living Centers. This study will also identify barriers that need to be overcome and facilitators that can be leveraged to improve its implementation in Community Living Centers and ensure its dissemination throughout VA. Our findings may also empower Veterans and their family caregivers by providing a template for them to engage in shared decision making with their healthcare providers to reduce their medication burden and improve the value of care that they receive.